Physical mechanisms of 3D cell motility

Project Summary
Cell movement through three-dimensional (3D) extracellular matrix (ECM) is an essential component of normal
physiology and disease, including wound healing and tumor metastasis. Understanding how cells move
through structurally diverse 3D matrices will be essential to design therapies aimed at controlling cell migration
in the body. During 3D migration, both metastatic tumor cells and wound healing fibroblasts are faced with the
same problem: how to efficiently move the bulky, stiff nucleus. While the power of actomyosin contractility is
essential for cells to move their nuclei in 3D matrices, it is not understood how it is regulated by the ECM
structure or physically coupled to the nucleus. An additional layer of complexity comes from the fact that the 3D
matrix structure can govern actomyosin contractility to dictate the type of protrusions cells use to move (i.e.
migratory plasticity). By understanding how the structure of the 3D ECM affects the physical properties of the
nucleus and actomyosin contractility, we aim to create a conceptual framework to explain how and why human
cells switch between distinct 3D migration mechanisms. We recently discovered that human cells moving in a
linearly elastic 3D matrix rely on integrin-based cell-matrix adhesions and the power of actomyosin contractility
to pull the nucleus forward, like a piston, and switch from using low-pressure lamellipodia to high-pressure
lobopodial protrusions. This project will test the hypothesis that mechanical stress on the nucleus reprograms
intracellular architecture and polarity to power the nucleus, and thereby the cell through 3D matrices. To
achieve these goals, we will combine biophysical and cell biology approaches to measure mechanical stress
on the nucleus and determine the molecular connections between discreet cytoskeletal elements required for
high-pressure 3D motility. Aim 1 will manipulate the physical structures of the matrix and the nucleus and
measure the ability of the cells to assemble and activate the nuclear piston mechanism. This approach will
establish why the 3D matrix can reprogram cellular force production to switch cells to pressure-driven 3D
migration. Aim 2 will identify the actomyosin machinery that is specifically activated by 3D matrix-cell
interactions to generate pressure and govern migratory plasticity. These experiments will clearly distinguish the
actomyosin filaments responsible for pulling the nuclear piston forward from those that respond to matrix
stiffness by increasing traction force. Aim 3 will determine the mechanisms by which vimentin intermediate
filaments transmit force to the nucleus to sustain intracellular polarization and directional cell movement in the
narrow confines of the 3D matrix. These novel approaches will determine if the nucleus is a mechanosensor
that responds to 3D matrix structure by governing actomyosin contractility and the mode of 3D cell migration.
This enhanced understanding of the fundamental principles of directional 3D cell motility and migratory
plasticity will lead to new therapeutic strategies to control normal and abnormal cell movement in the body.

Public health relevance
Project Narrative The movement of single cells through three-dimensional tissue environments is essential for physiological processes like wound healing, but is a lethal characteristic of metastatic tumor cells. The goal of this research project is to understand how cell behavior and architecture is reprogrammed in response to the structure of the material they are moving through. This information will help develop new therapeutic strategies to control the movement of normal and abnormal cells in the body.